Natural Speech Processing, the Influence of Prior Knowledge, and Auditory Hallucinations in Schizophrenia

Project Summary/Abstract
Auditory hallucinations (AH) are experienced by approximately 60-80% of individuals with
schizophrenia (SZ), and are often associated with significant distress and functional disability. Many individuals
who experience these symptoms do not respond adequately to standard treatments with antipsychotic
medication, and/or experience adverse side effects from these treatments. Thus, there is an urgent need to
better understand AH pathophysiology to inform the development of novel, targeted interventions. Recent
mechanistic models of psychosis suggest that AH may result from a pathological overweighting of expectations
relative to bottom-up sensory signals during perception, and that lower-level sensory processing impairments
in SZ may contribute to this pathology. Therefore, the goal of the proposed project is to investigate these
potential AH mechanisms by leveraging recent advances in the use of electroencephalography (EEG) to index
hierarchical processing of natural speech. The specific aims are to evaluate whether AH in SZ are associated
with: 1) impaired auditory processing of speech stimuli; and 2) alterations in the effects of prior knowledge
regarding speech content on the auditory processing of speech. Fifty-six SZ participants will be recruited,
specifically 28 with AH (AH+) and 28 without AH (AH-), along with a group of 28 matched healthy control
participants (HC). EEG will be recorded as participants listen to speech segments that are either unaltered or
acoustically degraded. EEG responses will be modeled to derive indices of auditory encoding of speech.
Measures of the effects of prior knowledge will be based on the lexical predictability of narrative speech, and
the manipulation of prior knowledge regarding the content of degraded speech. It is hypothesized that AH in
SZ will be associated with impaired auditory encoding of speech and a greater influence of prior knowledge on
this encoding, and that within AH+, these two alterations will be related. Results will provide data on
unanswered questions regarding AH mechanisms, and will be used to support an NIH grant proposal of a
larger, well-powered investigation of AH pathophysiology in psychotic disorders and of potential subgroups
with regard to underlying pathology. This work has the potential to inform the identification of novel therapeutic
targets for AH, along with biomarkers of underlying pathology that can be used to identify subgroups most
likely to benefit from particular intervention strategies. Given the significant unmet therapeutic need this line of
work aims to address, and its relevance to transdiagnostic mechanisms of psychosis and mechanistic
heterogeneity within diagnostic categories, these efforts are consistent with the public health mission of NIMH
and its Research Domain Criteria (RDoC) initiative.

Public health relevance
Project Narrative Despite substantial progress in recent years in identifying neural correlates of auditory hallucinations in psychosis, unanswered questions regarding underlying mechanisms have hindered the development of targeted interventions for affected individuals who do not respond adequately to standard treatments. The proposed research will employ cutting-edge electroencephalography (EEG) methods to investigate potential contributions of auditory processing impairments and alterations in the influence of expectations based on prior knowledge to these symptoms with the aim of informing mechanism-based interventions. Given the significant unmet therapeutic need this work aims to address, the proposed study is consistent with the public health mission of the National Institute of Mental Health.